Exploring the validity of articulatory impairment phenotypes in speech motor disorders

PROJECT SUMMARY
Speech motor disorders have profound impacts on an individual’s ability to communicate, often leading to a
significant reduction in quality of life35,49. Since the advent of personalized medicine, clinical phenotypes have
become an increasingly important construct in rehabilitation research, as they facilitate the identification of
treatment targets that are individualized to a patient’s unique impairment profile3. There is, however, currently
no established set of objective measures that to phenotype the articulation impairments observed in speech
motor disorders32. Consequently, clinicians employ broad treatment strategies for patients with distinct
articulatory deficits, which often result in variable therapy outcomes97. Given the links between specific
articulatory abnormalities and pathophysiologies1,16,81,90 and the impact of the articulatory subsystem on
intelligibility14,53,69,77, there is a critical need to determine the articulatory impairment phenotypes across the
spectrum of speech motor disorders. The proposed study will comprehensively characterize articulatory
impairments in four neurologic populations (compared to healthy controls) with hypothetically divergent motor
deficits: (1) the nonfluent variant of primary progressive aphasia (nfvPPA) or primary progressive apraxia of
speech (PPAOS), (2) amyotrophic lateral sclerosis (ALS), (3) Parkinson’s disease (PD), and (4)
spinocerebellar ataxia (SCA). Articulatory impairments will be characterized based on a hypothesis-driven
framework of motor control (i.e., Coordination, Consistency, Speed, Precision, and Rate) composed of a
semi-automated acoustic feature set. Aim 1 will use a linear discriminant analysis (LDA) to compare the
articulatory performance (as indexed by the acoustic feature set) of the groups during the sequential motion
rate (SMR) task. The LDA will be adjusted for speech severity to determine the true discriminatory power of the
acoustic features and ensure that severity differences are not driving phenotype differences. Aim 2 will use a
multiple regression analysis (MRA) to determine the articulatory deficits most associated with intelligibility in
the four neurologic populations by correlating performance on each acoustic feature with performance on the
Sentence Intelligibility Test (SIT)96. The overall goal of the proposed research is to advance our knowledge of
the diversity of articulatory impairment phenotypes in different speech motor subtypes. Results from this
research will (1) facilitate the development of impairment-based approaches, (2) yield more granular outcome
measures for evaluating the efficacy of behavioral or pharmaceutical treatments, and (3) elucidate the
contribution of distinct articulatory mechanisms to declines in functional communication. This project falls under
NIDCD’s Priority Area 3 in Voice, Speech, and Language Research, as it investigates biomarkers that could
support diagnosis, treatment, and progress monitoring in individuals with speech impairments. Furthermore,
this work is closely aligned with the strategic plan for behavioral phenotyping and is overall consistent with the
mission of NIDCD to further our knowledge and understanding of communication disorders.

Public health relevance
PROJECT NARRATIVE This project seeks to characterize the articulatory impairment phenotypes of four neurodegenerative populations with hypothetically divergent speech deficits using a novel acoustic-based framework of motor control. This study also assesses the unique impacts of each articulatory deficit on intelligibility in the four populations. The findings of this research are critical to (1) motivating the development of impairment-based treatments for patients with distinct articulatory phenotypes, (2) providing more granular outcome measures for evaluating treatment efficacy in clinical trials, and (3) understanding the underlying articulatory mechanisms that contribute to functional communication.